Effectiveness and Sustainment of a Tailored Over-the-Counter Medication Safety Intervention in Community Pharmacies

Project Summary/Abstract
Older adults are susceptible to over-the-counter (OTC) medication safety issues and harms related to
misuse. Not only do older adults use OTC medications more than other age groups, but their medication
selection often is not appropriate for their age, health conditions, or concomitant medications. They also are
frequently non-compliant with labeling instructions. Over 1 million older adults are at risk for a major adverse
drug event that involves an OTC medication. Although older adults represent an AHRQ priority population, no
effective interventions have broadly attempted to decrease OTC medication misuse harms in this population.
The transdisciplinary team, with experts in pharmacy, public health, geriatrics, human factors engineering,
biostatistics, mixed-methods analysis, and dissemination and implementation, will collaborate with Advocate
Aurora Health (AAH), a large health system with community retail pharmacies. This collaboration will lead to
the adaptation, adoption, and long-term evaluation of a system redesign intervention (the Senior Section) to
decrease OTC medication misuse for patients in 63 AAH pharmacies. Senior Section features include a
curated supply of safer OTC medications, cautionary signage, and tools to support OTC selection, which are
designed to facilitate older adult/pharmacy staff encounters about OTC issues.
The EPIS (Exploration, Preparation, Implementation, Sustainment) model will be the conceptual framework
used to ensure continual optimization of the Senior Section when applied to varied pharmacy settings. A Type
2 effectiveness-implementation hybrid design will: (1) adapt the Senior Section based on characteristics of
pharmacies and their patient population, (2) evaluate Senior Section effectiveness for reducing older adult
OTC medication misuse, and (3) evaluate implementation of the finalized Senior Section. Using insights gained
from pharmacy staff, older adult, and AAH stakeholders, the Senior Section will be adapted using eye-tracking
technology and pharmacist/technician interviews to identify features that patients use when selecting OTC
medications. These outcomes will be used to inform the development of an Implementation Package. For
effectiveness, a post-test randomized controlled trial (comparing test and control pharmacies) will be
conducted to evaluate the rate of OTC misuse and characteristics of pharmacy staff/patient encounters. Final
implementation by AAH without research team support will be assessed by fidelity of delivery, long-term
effectiveness, and perceptions about sustainability, which provide a signal of sustainment.
AAH leadership and front-line pharmacy staff are committed to adopting and evaluating this innovative
intervention in their pharmacies. This study responds to AHRQ patient safety priorities for system-level change
to improve medication use. Outcomes will address an unmet critical need, identified by AHRQ PA-20-028, to
“spread existing tools that have previously been used in limited settings, and thus enabling improvement on a
larger scale” for older adults, an AHRQ targeted population at high risk for OTC medication misuse.

Public health relevance
Project Narrative Adults older than 65 are more likely than other age groups to use over-the-counter (OTC) medications that place them at great risk for severe harms because of their age, health conditions, use of other medications, and divergence from the labeling instructions. This study will adapt and implement a pilot-tested system redesign intervention to reduce unsafe OTC medication use in a large health system. This innovative intervention will enhance patients’ awareness of and attention to risks inherent in OTC medications by facilitating communication between older adults and pharmacy staff around issues of OTC medication safety and, ultimately, reduce the public health harms related to OTC misuse.